Mechanisms underlying adult tendon regeneration in the zebrafish

Galloway, Jenna L Project Summary
Model organisms such as the zebrafish have advanced our mechanistic understanding of
regeneration, with the hope that this knowledge could eventually impact the design of treatments
for human injury and disease. Due to their important function in transferring load from the muscle
to the bone, tendons are often injured and yet, have limited healing potential in humans. Work in
the mouse has provided a cellular and molecular understanding of mammalian tendon healing.
However, in the mouse, as in all mammals, adult tendons do not regenerate. Instead, injuries heal
via scar formation, resulting in disorganized tissue with inferior properties. This application
proposes to use the zebrafish, a highly tractable genetic and regenerative model organism, to
study adult tendon regeneration. We have shown that TGFβ signaling is required for adult
zebrafish tendon regeneration and the contribution of scleraxis (scxa)-lineage cells to the healing
tissue. We also find decreased scxa:mcherry+ cells at the injury site upon reduced muscle activity
via Botox-injection to the neighboring muscle. As TGFβ signaling is thought to be downstream of
muscle activity in tendon development and homeostasis, we propose to examine the relationship
between TGFβ signaling and muscle activity in tendon regeneration. First, we will investigate how
reduced TGFβ signaling and muscle activity affect the cellular composition and fate of the cells
involved in regeneration. Using an inducible genetic system, we will test the temporal and spatial
regulation of TGFβ signaling in scxa-cell recruitment and tendon regeneration. Finally, we will test
if diminished muscle activity alters TGFβ signaling and if activation of TGFβ signaling can rescue
the disruption to scxa-cell recruitment and tendon regeneration. Using a transcriptomics
approach, we also aim to discover new pathways that are differentially regulated in regenerative
compared with non-regenerative contexts and test their function in regeneration. Together, these
aims will provide new mechanistic insight into the role of TGFβ signaling and muscle activity in
tendon homeostasis and regeneration and hopes to impact future tendon treatment strategies in
humans.

Public health relevance
Galloway, Jenna L Project Narrative Tendon injuries, ranging from tendinopathies to acute tears, are widespread and present clinical challenges due to their limited healing potential. This proposal takes advantage of the zebrafish, a highly regenerative genetic model system, to gain mechanistic insight into tendon regeneration. Knowledge gained from these studies will impact the framework in which we approach the development of regenerative therapies for human tendon injuries.